Intra-Individual Changes in Ambulation and Functional Outcomes among Frail Elders

Behavioral changes associated with ambulation activity among older adults with dementia may indicate
underlying physiological vulnerabilities. Using a real-time locating system (RTLS), work by the author
shows intra-individual changes in ambulation activity (e.g., continuous ambulation) are meaningful
changes in behaviour associated with fall vulnerability in a population of institutionalized older adults
with dementia and may indicate the onset of acute medical conditions. Other research using RTLS
technology in a similar sample suggests increased tortuosity (e.g., random changes in direction during
movement) and/or the onset of dementia-related wandering behaviours (lapping and pacing ambulation
patterns) may be linked to a fall and other acute changes in physical health. Thus, changes in the
quantity (e.g., increased time and distance travelled) and/or quality (e.g., random changes in direction,
lapping and pacing patterns) of ambulation activity may increase fall vulnerability as these older adults
are ambulating more or in a more tortuous path or may be an early sign of an acute medical condition
that the person cannot communicate.
Specific Aim 1, Study 1: With a larger more heterogeneous sample, test a new model of ambulation
activity. H1a: Intra-individual changes in ambulation activity (e.g., path characteristics, tortuosity) will be
significantly associated with a fall H1b: and the onset of acute medical conditions.
Specific Aim 2, Study 2: Enhance the predictive capability of the model to capture patterns of
changes in ambulation activity associated with acute changes in physical health. RQ: How will using
innovative predictive analytics such as random forest (RF), partial least squares (PLS) and linear
classifiers to identify additional predictive factors and ambulation patterns (e.g., lapping, pacing)
improve the predictive capability of the model?
Specific Aim 3, Study 3: Translate model findings in to clinical strategies that may be used to modify
individual plans of care. Rationale: Findings from machine-learning approaches may need additional
interpretation to be clinically feasible; identifying underlying mechanisms through collaboration with
experts in a descriptive pilot and translating these into practice with focus groups of VA CLC clinicians
will lead to strategies that may be used in VA CLC's to improve patient care.
Study Design: A prospective longitudinal natural history study design will be used in Study 1. In Study
2, a predictive modeling design will be used to identify additional factors that improve the predictive
capability of the model. In study 3, a qualitative study design will be used.
Methodology: In Study 1, ambulation activity including time and distance travelled, gait speed, path
characteristics (e.g., continuous walking), ambulation patterns (lapping and pacing) and tortuosity
(random changes in direction and movement) will be measured continuously by a RTLS and
associated with falls and acute medical conditions for up to 2 years. Study 2 will use historical data
from Aim 1, machine learning and other statistical techniques including random forest (RF), partial least
squares (PLS) and linear classifiers to examine additional factors and combinations of factors
associated with falls and acute medical conditions. In study 3, with experts, clinical staff focus groups
will be used to identify and explore clinical strategies that may reduce fall risk and the early
identification of acute medical conditions
Impact: This work will lead to a better understanding of behavioral changes associated with ambulation
activity and how these changes may lead to an increased risk for acute changes in physical health.

Public health relevance
The Veteran population is older than the general population with a unique set of care needs. In general, the Veteran population is more likely to have dementia or cognitive impairment, co-morbid conditions and psychiatric illness. Thus, many older Veterans depend on VA Community Living Centers (CLC's) for skilled nursing care. Falls and acute medical conditions (e.g., urinary tract infections, pneumonia) are the most common acute physical health conditions in VA CLC's. These health conditions represent increasing physical vulnerability, are costly and associated with poor patient outcomes --- including de- conditioning, hospitalization and death. This research proposal will lead to rehabilitation strategies designed to identify Veterans becoming increasingly vulnerable to an acute physical health event, promoting increased quality of life while reducing healthcare utilization and acute care costs among older adults with dementia in VA CLC's.